Maintaining Preventive Care during Public Health Emergencies through Effective Coordination

BACKGROUND. Screening lies at the heart of preventive care. However, COVID-19 has dramatically disrupted
routine screening efforts, resulting in excess veteran mortality not directly attributable to COVID-19. Screening
rates at VA during COVID have varied markedly by facility and clinical condition. This is illustrated in cancer
and mental health screening; cross-facility variability exists for each, suggesting susceptibilities in the capacity
and workflow of the screening and referral process. To better understand these susceptibilities and identify
new practices to mitigate interrupted care, we propose a qualitative study comparing facilities that exhibited
high, low, and highly variable performance (respectively) in screening rates before and during the pandemic.
SIGNIFICANCE. Disruptions to preventive screening lead to excess veteran mortality. Therefore, caring for
veterans’ regular primary care (PC) needs while fulfilling our Fourth Mission (emergency preparedness)
requires top-notch coordination and nimble teamwork from all clinical personnel. Our study will identify the
systematic strategies and coordination patterns between primary and specialty care that differentiate
successful facilities from struggling ones. Our findings will help design new or adapt existing workflows and
interventions for coordination, shaping how screening and preventive care is delivered during and beyond
COVID-19. Our study directly addresses: a) this solicitation’s goals; b) HSR&D’s clinical priorities; c) VA’s
strategic plan goals for highly reliable care; and d) ORD real-world research impact priorities.
SPECIFIC AIMS. Using cancer and mental health screening rates as exemplars, we propose to (1) Compare
how PACTs from VHA facilities of varying screening performance patterns (high, low, improving, plummeting,
variable) during the COVID-19 pandemic coordinated (a) as a team to conduct screening services, and (b) with
specialty care teams at their facility to conduct screening services; and (2) Compare team, facility, and system-
based barriers, facilitators, and strategies for continuing screening services during the COVID-19 pandemic
amongst PACTs from VHA facilities of varying screening performance patterns during that period.
METHOD. Design and Participants. This multi-method study consists of qualitative analysis of interviews and
focus groups with primary care personnel, leadership, and patients at 10 VA Medical Centers (VAMCs).
Site Selection. We will select study sites using a purposive stratified approach based on site rurality, COVID-19
caseload at the beginning of the pandemic, and performance on five outpatient clinical performance indicators
of cancer and mental health screening. Sites will be categorized into one of five screening performance
groups: high performers, low performers, improvers, plummeters, and highly variable.
Procedure. Using data from prior research by the PI, we will create process maps for each performance
measure to create a baseline for comparison to the process used since the pandemic began. We will interview
the ACOS for primary care at each site to update the map to reflect the currently used process. We will
conduct focus groups with PC and relevant specialty care clinicians to elicit themes regarding clinician
coordination patterns (e.g., handoffs), strategies, and barriers/facilitators to screening during COVID (Aims 1-
3). We will also conduct patient interviews to examine their screening experience during this period, for
context.
Data Analysis: All interview and focus groups will be audio-recorded, transcribed, and enhanced by field notes.
We will analyze clinician focus group transcripts and field notes using iterative, rapid analysis. Patient semi-
structured interviews will be analyzed using inductive/deductive content analysis.
NEXT STEPS/IMPLEMENTATION. We will share our findings, including site-specific recommendations, locally
with key stakeholders at participating sites, and nationally through the Office of Primary Care-Mental Health
Integration program and the VA National Women Veterans Oncology System of Excellence.

Public health relevance
Timely screening for serious conditions lies at the heart of effective preventive care and can help prevent poor health outcomes and mortality among Veterans. However, COVID-19 dramatically impacted preventive screening efforts in the US and elsewhere, by shuttering clinics that conducted in-person screenings for “high- touch" conditions such as cancer, and by making coordination with specialists, such as mental health providers, more difficult. Our study seeks to better understand and optimize screening workflow within VA primary care teams, and between primary and specialty care teams within during such crises, in order to maintain continuous, high-quality screening service to Veterans regardless of public health conditions. Our findings will contribute to the VA’s ability to fulfill its “Fourth Mission” of providing resources and assistance to all Americans during national emergencies.